PHARMACOKINETICS OF CYCLOSPORINE IN BONE MARROW TRANSPLANT PATIENTS

The goal of this pilot study is to obtain cyclosporine pharmacokinetic profiles in the bone marrow transplant recipient for comparison with other transplant cohorts. Differences in profiles may indicate the need for more specific dosing guidelines in the bone marrow transplant recipient. The methodology for measurement of cyclosporine pharmacokinetic profiling requires the subject to be admitted to the General Clinical Research Center for serial blood samplings over a 12 hour dosing interval.